The Ability of the Inhaled Dronabinol to Reduce the Severity of Naloxone-Precipitated Withdrawal

PROJECT SUMMARY
Despite having distributed thousands of doses of naloxone (NLX) to those at risk of witnessing an opioid-
related overdose, deaths in the U.S. remain high. Our research has found that the fear of precipitating
withdrawal often makes individuals hesitant to administer NLX, even in life-or-death situations. Meanwhile,
once revived, the adverse withdrawal symptoms may lead the overdose victim to seek opioids for relief, putting
them again at risk of overdose. The goal of the proposed R21 application is to test the ability of a novel inhaled
formulation of the drug dronabinol (synthetic THC), to reduce the severity of NLX-precipitated withdrawal. The
endocannabinoid system is a novel target for reducing opioid withdrawal severity. Preclinical studies have
demonstrated that THC decreases signs of opioid withdrawal in morphine-dependent rodents. In humans, oral
dronabinol and smoked cannabis have been shown to reduce the severity of opioid withdrawal during opioid
detoxification and stabilization. Additionally, in the clinical laboratory, cannabinoids have been shown to have
analgesics effects that may provide relief from the muscle and joint pain commonly seen during opioid
withdrawal. For this randomized, double-blind, placebo-controlled, inpatient, clinical laboratory study, inhaled
dronabinol (.00, .35, .70 mg) will be combined with intranasal (IN) NLX (0.0, 0.2 and 0.4 mg). This
investigation will recruit healthy participants with Opioid Use Disorder (N=16). Testing will begin following 5-7
days of stabilization on oral morphine (30 mg, QID). During each testing session, a single dronabinol +
naloxone dose combination will be assessed with 48 hours between testing sessions (> 5 half-lives via this
route). Laboratory testing sessions will consist of a modified naloxone challenge procedure (Wang Test) that
our division has used for over 15 years. The challenge begins with baseline assessment of opioid withdrawal,
measurements of miosis (pupil diameter; an indicator of mu-opioid receptor activation), and vital signs.
Common symptoms of opioid withdrawal will be assessed by a blinded research nurse. Each symptom is
coded as either “absent” or “present” points added when a symptom is observed. Following pre-test
assessments, the physician will administer the study drug combination. Assessments of withdrawal are made
at 10-minute intervals up to 50 minutes after study drug. The total withdrawal score is calculated at the end of
the session. The Subjective and Clinical Opioid Withdrawal Scales also be utilized. The primary aim of this
project is to assess the ability of dronabinol to alter the severity of NLX-precipitated withdrawal (dependent
variable (DV): total withdrawal score). Secondary aims include: the safety of inhaled dronabinol in combination
with naloxone (DV: non-withdrawal-related adverse events & physiological parameters), the effects of
dronabinol on naloxone’s antagonism of the µ-opioid receptor (DV: pupil diameter), and the abuse potential of
inhaled dronabinol (DV: subjective drug liking). This proof-of-concept study may identify a novel, more
tolerable, emergency pharmacological intervention for opioid overdose.

Public health relevance
PROJECT NARRATIVE In medical settings, treating opioid overdose using naloxone can lead to adverse patient reactions that put staff at risk and increase the likelihood of discharge against medical advice. The fear of inducing withdrawal may also prevent the use of naloxone by non-medical persons (e.g., other drug users and family members) who witness an opioid overdose. This investigation proposed a new pharmacological approach that could greatly improve the effectiveness and tolerability of opioid overdose intervention by combining it with another medication capable of attenuating precipitated withdrawal.